Administration and Engagement Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATION AND ENGAGEMENT CORE
The Administration and Engagement Core (AEC) has primary management and oversight responsibility for all
Breast SPORE activities, which includes direct support to investigators and organizational components of the
SPORE, planning, coordination and management of all scientific and administrative collaborations with the NCI,
other SPOREs and partner universities, departments and agencies. This includes direct responsibility and
oversight for the solicitation, administration and management of the Developmental Research Program (DRP)
and Career Enhancement Program (CEP), ensuring these projects will coincide with the beginning of each new
budget period of the Breast SPORE. In addition, AEC is responsible for: developing and coordinating the
administration of planning and evaluation activities, Internal Advisory Board (IAB) and External Advisory Board
(EAB) meetings, and review and reconciliation of financial expenditures. In addition, The AEC prepares required
and necessary reports to ensure compliance with all federal regulations and reporting requirements.
Furthermore, AEC works closely with Breast SPORE investigators, core directors, and CEP and DRP recipients
to ensure compliance with the NIH Public Access Policy on publications related to SPORE activities. The AEC
is also responsible for monitoring and managing financial resources from all SPORE-related activities, as well
as both the NCI and Vanderbilt University Medical Center (VUMC) for the SPORE. With the addition of the
contractual arrangements with the University of Texas Southwestern (UTSW) for Project 1 and Vall d’Hebron
Institute of Oncology (Barcelona, Spain) for Project 3, the AEC will provide financial and programmatic oversight
of these subcontracts and will collaborate with the UTSW and Vall d’Hebron teams to ensure compliance. The
AEC recruits and facilitates communications and interactions of research patient advocates with SPORE
investigators, and meets monthly to discuss operational and administrative needs, scientific progress, and
reviews financial status of the SPORE.

Public health relevance
PROJECT NARRATIVE: ADMINISTRATION AND ENGAGEMENT CORE The Vanderbilt-Ingram Cancer Center (VICC) SPORE in Breast Cancer Administration and Engagement Core (AEC) has primary management and oversight responsibility for all Breast SPORE activities, which includes direct support to investigators and organizational components of the SPORE, planning, coordination and management of all scientific and administrative collaborations with the NCI, other SPOREs, partner universities, departments, and agencies and interactions and collaborations with the patient and advocate community. The Breast SPORE AEC focuses on the translational research contributing to improved prevention, early detection, diagnosis and treatment of breast cancer.